Faculty Recruitment for the University of Rochester Center for RNA Biology Core

DESCRIPTION (provided by applicant): This proposal presents the rationale for a request for initial funds to hire a new tenure-track faculty member in the RNA Center for Biology at the University of Rochester Medical Center. The faculty member will join a highly integrated and interactive group of 16 research scientists with a shared interest in the structure and function of RNA. The recruitment plan leverages these strengths and seeks to broaden the Center's multidisciplinary scope by adding a scientist with expertise in the area of small RNA function. The proposal outlines a broad array of existing academic and research career development support services designed to ensure the successful mentoring of a new junior faculty member. Moreover, the new faculty member will have full access to outstanding core research facilities and a vibrant, integrated graduate training program. The proposal envisions the appointment of the recruit to one of several established degree-granting programs in the basic biomedical sciences and mentorship by a core group of outstanding academic scientists. Finally, the URMC is committed to full financial support of the recruited faculty member for 3 years beyond the funds requested by this proposal.

Public health relevance
This proposal describes efforts to hire a new junior-level academic scientist to join the University of Rochester Center for RNA Biology Core. This addition will significantly strenghten the Core's central mission, which is to understand the structure and function of RNA and to develop medical interventions to treat human disease.